Effects of HIV Rev on Host Cell Gene Expression

It is well established that all retroviruses have evolved processes to overcome the usual regulatory
mechanisms of the cell that control or restrict the nucleocytoplasmic export of RNA until splicing is complete. A
hallmark of every retroviral transcriptome is that viral mRNA with at least one retained intron reaches the
cytoplasm. In the case of HIV infected cells, many different viral RNAs with one or two retained introns appear
in the cytoplasm, and it is the binding of the Rev protein to a cis-acting element, the Rev Response Element
(RRE), present in all of these RNAs, that facilitates this process. This proposal will explore the hypothesis that,
in addition to facilitating the export and expression of viral RNAs with retained introns, Rev interacts with RNA
elements present in bona fide cellular genes and human endogenous retroviruses, to overcome the
mechanisms that normally control and restrict the export of RNA isoforms with retained introns. Novel RNA
isoforms, whose expression has been dysregulated by Rev, may function to change the milieu of the infected
cell to affect innate immunity and/or promote viral replication, either directly, or by being translated into a novel
protein isoforms.
The proposal has 2 specific aims:
In Aim #1 we will identify cellular RNAs that functionally interact with Rev. This will be accomplished
through the use of a novel vector-trap system. This will allow the isolation of cellular sequences that function
like RREs (cRREs) and identify genes with potential to be regulated by Rev. In Aim #2 we will perform
RNASeq on SupT1 cells transduced with retroviral vectors that express Rev or both Tat and Rev and identify
genes that have novel RNA isoforms expressed in the cytoplasm.
At the completion of this R21, we expect to have determined whether HIV Rev can induce the
cytoplasmic expression of novel RNA species at the post-transcriptional level through interaction with cRREs.
Further experiments, beyond the scope of this two year proposal, will analyze how this novel Rev-mediated
post-transcriptional regulation of cellular RNAs influences HIV replication and cellular functions.

Public health relevance
Project Narrative We will test the hypothesis the HIV Rev protein functionally interacts with cellular RNAs to induce the nucleo-cytoplasmic export and expression of novel RNA isoforms. These studies will determine how Rev- mediated post-transcriptional changes in the cellular transcriptome influence HIV replication and identify cellular genes that could be targets for the development of novel therapeutics.